Bioinformatics Core

PROJECT SUMMARY
BIOINFORMATICS CORE
Increasingly, the fields of medicine and biological sciences produce large quantities of complex data that
requires analysis by new statistical and computational approaches. The overall goal of the Arkansas INBRE
Bioinformatics Core is to build bioinformatics research capabilities through education, training, and enhanced
access to state-of-the-art computational infrastructure and tool sets. The Bioinformatics Core will continue to
address the national need for bioinformaticians through ongoing support and development of bioinformatics
educational programs at both the undergraduate and graduate levels. The Bioinformatics Core will provide
critical support in the development of fundamental infrastructure that includes hardware, software, and
intellectual resources that will foster new computational methodologies. Finally, the Bioinformatics Core will
provide training for biomedical researchers, educators, and students at Arkansas INBRE network institutions to
use bioinformatics resources to conduct biomedical research and enrich undergraduate science curriculum.